Role of Ribosome Hibernation in the Tolerance of P. aeruginosa Biofilms to Antibiotics

Bacteria living in biofilms are less susceptible to antibiotic treatments than free-living planktonic cells.
One mechanism for this increased antibiotic tolerance is that biofilms contain physiologically
heterogeneous subpopulations of cells, including antibiotic-tolerant dormant bacteria. When bacteria
enter a dormant state, they undergo a variety of physiological changes that reduce energy-expensive
processes, yet protect the integrity of macromolecules required for resuscitation. Among these
physiological changes is inactivation and preservation of ribosomes. The ribosome accessory proteins
(RMF and HPF) are hibernation factors that block translation and protect ribosomes from degradation
when the cells are dormant. By protecting ribosomes, ribosome hibernation factors enable the cells to
resuscitate from dormancy when conditions are favorable, resulting in persistent infections. Ribosome
entry into and exit from hibernation are dynamic processes, and biofilm subpopulations have cells with
ribosomes in differing states, depending on the local environmental conditions. In the research
proposed here, we will characterize the role of ribosome hibernation in the antibiotic tolerance of
biofilm bacteria, by characterizing protein-protein interactions between ribosomal proteins and
ribosome accessory factors. In preliminary work, we developed a bimolecular fluorescence
complementation (BiFC) system that allows real-time fluorescence-based imaging of ribosome
dynamics in Pseudomonas aeruginosa biofilm cells. This system allows us to image biofilm bacteria
with hibernating ribosomes, and to sort the cells based on their ribosome state. The BiFC system also
allows us to identify additional ribosome hibernation factors, such as molecular chaperones, that
mediate the loading of hibernation factors. The goals of these studies are to: (i) generate molecular
constructs that provide optimal fluorescent reporter signals for bacteria with ribosomes in active and
hibernating states. (ii) Use the fluorescent reporter systems to identify and sort active from dormant
bacteria over the course of biofilm development, and compare their antibiotic sensitivity profiles, and
(iii) identify additional dormancy factors that contribute to the antibiotic tolerance of dormant biofilm
cells. Since many commonly used antibiotics target bacterial translation, the ultimate goal of these
studies is to identify molecular targets that, when disrupted, enhance biofilm sensitivity to ribosome-
targeting antibiotics. Targeting ribosome hibernation factors, or their molecular chaperones, may
provide a means to inhibit the viability of dormant bacteria, thereby increasing biofilm sensitivity to
antibiotics.

Public health relevance
Most antibiotics target active bacterial metabolism, and are less effective against dormant bacteria. Subpopulations of bacteria growing on surfaces enter a dormant state and are resistant to antimicrobial therapy. In this research, we will characterize the interactions of ribosomes with ribosome hibernation factors to identify how ribosome hibernation influence the resistance of bacterial cells to antibiotics.